Lipid Antigens for iNKT Cells in the Gut Microenvironment

Project Summary
The gut microbiota is recognized as a central factor influencing immune responses. This proposal addresses
two important questions in understanding how microbes regulate human health: 1) What are the microbe-
derived molecules that influence immunity? 2) How does chronic exposure to microbial products alters the
phenotype of immune cells in their local environment? Discovering and characterizing the molecules involved
in the crosstalk between symbiont microbes and the immune system is a fundamental step towards modulating
both the beneficial and harmful potential of the human-microbe relationship.
The first major aspect of this project (Aims 1 and 2) uses a series of biochemical approaches to define specific
bioactive microbial lipids from human-derived gut microbes that activate invariant natural killer T (iNKT) cells, a
specialized lymphocyte subset that recognizes specific lipids as antigens and orchestrates immune responses
in multiple contexts. Although animal models have uncovered a role for iNKT cells in immunity, the lipid
antigens that they recognize remain unknown in most situations. Here, we study two human symbiont
microbes that produce iNKT cell-activating lipids, an uncommon feature among gut anaerobes. To identify the
specific molecular lipid species that activate iNKT cells, we will use a newly-developed method, the “T cell
receptor trap,” to capture antigenic lipids. Once purified, these lipids will be characterized by mass
spectrometry, including new methods that distinguish sugar stereochemistry, which is of central importance to
the activity of lipids that activate iNKT cells.
The second major aspect of this project (Aim 3) builds on preliminary transcriptomic data to investigate how
chronic exposure to lipid antigens affects the phenotype of iNKT cells in the gut in a mouse model. Since iNKT
cells orchestrate immune responses in many situations, and can be either beneficial and harmful, changes to
their phenotype in the gut is likely to alter the course of enteral infection, inflammatory bowel disease, colon
cancer, or food allergy. To understand how lipids in the gut regulate iNKT cell populations, we will use two
reductionist models, feeding mice with experimental diets containing different levels of iNKT cell lipid antigens,
or colonization of germ-free mice with lipid antigen-producing microbes. In these models, we will perform high-
depth phenotyping of the gut iNKT cell populations.
Together, these studies will define lipid antigens from two important members of the human gut microbiota and
shed light on the mechanisms by which gut lipid antigens shape iNKT cell populations.

Public health relevance
Project Narrative The microbes present in our gut have a profound impact on health, and profoundly influence the human immune system. In this proposal, we characterize specific immunologically-active lipids produced by the microbes in our intestines. We further investigate how these lipids shape immunity by regulating natural killer T cells, a specialized group of immune cells that recognizes lipids.